Regulation of Oxytocin Receptor Signaling in Neurons

PROJECT SUMMARY/ABSTRACT
Social deficits are a prominent feature of autism spectrum disorder and many other
neuropsychiatric diseases. Since there are currently no drugs available to treat these debilitating
symptoms, it is critical to decipher the neuronal mechanisms underlying social behavior and their
impairments in mental illnesses. Oxytocin, first discovered as a hormone that strengthens
contractions during labor and facilitates lactation, has subsequently been found to have a critical
role as a neuromodulator regulating social behavior. Recent work has begun to clarify how
oxytocin acts on neuronal circuits to modify inter-neuronal communication and circuit properties.
However, there is a large gap in the understanding of the intracellular signaling pathways that are
activated by oxytocin acting on its receptor in neurons. In particular, the regulatory mechanisms
that control oxytocin receptor signaling in neurons remain unexplored. Our preliminary findings
suggest robust and rapid-onset desensitization of oxytocin receptor response in multiple regions
of the mouse brain. Here, we propose to investigate the molecular mechanisms and behavioral
role of this process in the brain. Based on our generation of novel oxytocin receptor mutants that
do not undergo desensitization, we will characterize the molecular determinants that control
oxytocin-induced recruitment of the desensitizing machinery, G protein coupling and receptor
internalization in neurons and the brain. The behavioral role of oxytocin receptor desensitization
in controlling social behaviors will be tested by replacing endogenous oxytocin receptor in specific
brain regions with non-desensitizing mutants using CRISPR-Cas9 technique and virus delivery.
In addition, this proposal will dissect the inhibitory effect of a novel protein complex that we
identified in our proteomics experiments to associate with oxytocin receptor in neurons. The
investigations proposed here will provide a comprehensive test of our overall hypothesis that
neuronal oxytocin receptor is under tight regulatory control of receptor desensitization that limits
its signaling and that inhibiting this process would enhance oxytocin signaling and oxytocin-
dependent social behaviors. Completion of this work will provide deep insights into regulatory
mechanisms governing an important G protein-coupled receptor in the brain and may uncover
novel targets for the future development of therapeutic agents that alleviate social deficits in
neuropsychiatric disorders.

Public health relevance
Project Narrative The proposed project will decipher the regulation of critical neuromodulator signaling that mediates social behavior and is disrupted in brain disorders. The knowledge gained through this effort may lay the foundation for development of therapeutics strategies for alleviating social deficits in neuropsychiatric illnesses such as autism spectrum disorder.